North Dakota Drug Residue Prevention Program

Project Summary/Abstract As New Angus, LLC moves forward with the reopening of the former Northern Beef Packers slaughter facility in northern South Dakota, we are poised to see a significant increase in the number of North Dakota beef and dairy animals moving directly from farms or ranches to the point of processing into human food. Understanding and employing Best Management Practices by producers and adherence to adequate withdrawal periods will be critically important to ensure drug residue free foods. Although it is a separate issue, the public's concern with the use of antimicrobial drugs in animal health programs and how it relates to antibiotic resistant bacteria affecting human health care is integrally related. FDAs Judicious Use Initiative places the use of medically important antibiotics under the control of veterinarians by re?categorizing those products as Veterinary Feed Directive (VFD) drugs. The majority of North Dakotans in the livestock industry want to do the right thing. Currently, many livestock producers are not aware of all that is expected of them when administering drugs to food producing animals, for example the keeping of written treatment records. Not all veterinarians appreciate their responsibilities for assuring drug residue free animal derived foods. Few veterinarians and producers have begun to understand the requirements for the legal distribution of VFD products. Complicating matters, several entities are starting to conduct informational meetings on the issue and various interpretations of the new rules are presented creating a degree of confusion. Our proposal is built on the premise that livestock producers tend to rely on advice from people they know and the people that know those producers operations. Veterinarians, Extension Agents, and local agri?businesses are the most trusted sources of information. We will be working with FDA, our state veterinarians, Extension Specialists, and private industry to develop a consistent message which will be supported by jointly created handout materials and a packaged Power Point presentation. Laptops preloaded with the presentation and projectors will be loaned to those veterinarians, Extension agents, public employees, or others that attend a train the trainer course. Audience response technology will be used to evaluate communications effectiveness. Follow?up surveys will be used to measure the implementation of principals taught. After the conclusion of the cooperative agreement in three years, the working relationships established can continue to effectively conduct educational outreach.

Public health relevance
Project Narrative Implementation of the FDA Drug Residue Cooperative Agreement Program (U18) will promote enhanced animal health management practices by producers and ensure the elevated safety of animal based foods. An additional benefit of the program will be the establishment of a framework for future collaborations between FDA, state/county public entities, and private practitioners to develop and communicate consistent educational outreach to affected stakeholders.